A QUANTITATIVE, PREDICTIVE MODEL OF VASCULAR REMODELING IN HEALTH AND DISEASE

Summary
The vascular system constantly remodels in response to tissue growth or changes in metabolism to efficiently
deliver nutrients and oxygen to tissues. Remodeling encompasses sprouting angiogenesis, arteriogenesis and
expanding vessel diameters. Failure of these mechanisms contributes greatly to coronary artery disease,
peripheral artery disease and cerebral vascular dysfunction. While many genes and signaling proteins in these
processes have been identified, our incomplete understanding of regulatory networks impedes identification of
therapeutic targets and development of new treatments for these conditions. Vascular remodeling is regulated
principally by VEGF secreted by ischemic cells of the target tissues, and fluid shear stress (FSS) from blood
flow that act on vascular endothelial cells (ECs). Our recent work has revealed novel aspects of FSS-
dependent remodeling and interactions between FSS and VEGF that determine these processes. But we
know little about how these pathways interact to determine tissue-level outcomes. The Kholodenko lab has
developed a powerful new method called cell State Transition Assessment and Regulation (cSTAR) for
exploiting `omics' data to develop pathway models that can accurately encompass cell regulation, predict
outcomes, and identify therapeutic targets. Our three labs will work closely together to acquire quantitative
data on interactions within vascular remodeling regulatory networks and develop a quantitative model of
vascular remodeling that will be tested in vitro and in vivo. Aim 1 will address the roles of VEGF and FSS in EC
fate decisions during angiogenesis and arteriogenesis. Here, we will perturb candidate mediators of FSS and
VEGF signaling and measure effects on signaling and gene expression pathways. cSTAR will then identify
and precisely quantify causal connections in the regulatory network that guides EC phenotypic transitions to
allow purposeful manipulation of EC states and fate decisions, which will then be tested experimentally in vitro.
Aim 2 will utilize a similar strategy to address the effects of low, physiological, high and oscillatory FSS that
determine artery diameter and disease susceptibility. We will first characterize the effects of FSS profiles on
pathway activation, then carry out a perturbation study to determine effects of inhibiting pathways on EC
signaling and gene expression. cSTAR will again develop a causal computational model and generate
predictions that for testing in vitro. Aim 3 will then test predictions in vivo in mice, deleting candidate genes and
observing the impact on vascular remodeling. Together, these studies will develop a novel experimental-
computational approach to elucidate in unprecedented depth the regulatory networks that govern vascular
remodeling and develop insights into these biological processes that identify novel therapeutic targets for
improving vascular insufficiency in coronary, peripheral and cerebral artery disease.

Public health relevance
Narrative This project consists of an integrated experimental-computational strategy to elucidate in depth the regulatory networks that govern angiogenesis, arteriogenesis and vascular remodeling. We will acquire quantitative experimental data on effects of specific perturbations on the signaling and gene expression pathways that govern endothelial responses to VEGF and fluid shear stress, from which w cSTAR will develop a quantitative causal model. Key model predictions will then be tested experimental in vitro and in vivo.